West Virginia University Stroke COBRE

Abstract. Stroke is a leading cause of death and disability in the US and the world, and a significant health
burden in West Virginia (WV). Furthermore, stroke survivors often have persistent cognitive, affective, and
sensorimotor deficits, which substantially compromise quality of life. Unfortunately, effective approaches for
preventing and treating stroke remain an unmet need; continued investment in foundational research is needed
to develop novel solutions for preventing and treating stroke. For these reasons, the West Virginia University
(WVU) Stroke CoBRE focuses on promoting foundational research into risk factors for stroke, biological
mechanisms underlying neuronal damage, novel therapeutics, and strategies to stimulate post-stroke recovery
of cognitive and behavioral function. Phases I and II of the WVU Stroke CoBRE were highly successful in training
16 Research Project Leaders (RPLs); eleven “graduates” have secured independent research funding. The five
remaining RPLs, holding appointments during the latter half of Phase II, have submitted 9 grant applications and
are vigorously pursuing independent funding. The RPLs and the broader stroke research community have been
supported by the Rodent Experimental Stroke and Surgery (RESS) Core and the Rodent Behavior Core (RBC),
which eliminate the substantial barriers to conducting rigorous, state-of the-art in vivo stroke research. Both cores
are highly productive; the RESS Core performs more than 3000 procedures/year, and the RBC is in use an
average of ~7.2 h/day. Furthermore, the RESS Core and RBC work together to offer leading-edge 2 photon (2P)
microscopy that allows monitoring and manipulation of individual neurons during a behavioral task, which is
crucial for understanding how stroke alters the function of individual neurons and their networks to influence
behavior. The services and expertise offered by the RESS Core and RBC are not otherwise available at WVU,
or elsewhere in WV; a sustainable future for these scientific cores is crucial for serving stroke researchers in WV.
This objective will be achieved through three Specific Aims: Aim 1 is to further expand the critical mass of
investigators conducting stroke research through initiation of a Pilot Project Program (PPP) that catalyzes the
scientific and professional development of aspiring stroke researchers, especially early-stage investigators (ESI)
and new investigators (NI), through holistic mentoring. In addition, a voucher program will be used to offset the
cost of core use by ESI, NI, and other unfunded faculty who need preliminary data to pursue grant applications.
Aim 2 is to optimize and solidify the scientific cores, ensuring that they remain leading-edge and responsive to
the evolving needs of the stroke research community. Aim 3 is to implement a fee-for-service business plan that
will promote long-term sustainability of the RESS Core and the RBC. In summary, the overarching goal of the
WVU Stroke CoBRE in Phase III will be to sustain the scientific momentum created by reaching a critical mass
of foundational stroke researchers with the PPP, while enacting a shift to fee-for-service within the scientific
cores, which will promote sustainability without compromising the excellence or innovative edge of the cores.

Public health relevance
Narrative Phases I and II of the West Virginia University (WVU) Stroke CoBRE were successful in training 16 RPL graduates to high levels of productivity. We will build upon these successes in Phase III by expanding the number of investigators conducting stroke research, expanding the scope, capacity and user-base of our two high functioning research cores, and migrating to a fee-for-service model along with a voucher program to promote long-term sustainability of the Rodent Experimental Stroke and Surgery (RESS) Core and Rodent Behavior Core (RBC).